Development of a Next-Generation Nucleic Acid Force Field

PROJECT SUMMARY/ABSTRACT
Nucleic acids (NAs) are the major information carrying molecules of life. The ability to use
computation to model the structure, dynamic and interactions of DNA and RNA is a key adjunct
to experimental study of these biomolecules. For example, pseudouridine-containing mRNA
vaccines against Covid-19 are a critical tool in battling the pandemic. DNAs, mRNAs, and
miRNAs are targets for a number of antibacterial and antiviral drugs. Design of small molecule
drugs binding to nucleic acids in the treatment of cancers and neurodegenerative diseases is
one of the hottest topics of current pharmaceutical research. Under this project, we will
investigate several key aspects of nucleic acids, and develop the polarizable multipole
AMOEBA+ model for simulation of NAs and their interactions. This new force field will be further
enhanced via coupling of a machine learning-based potential for local valence features with
classical long-range nonbonded interactions. The resulting AMOEBA+NN force field promises
chemical accuracy in the calculation of binding for NA systems. Parameters for the AMOEBA+
and AMOEBA+NN potentials will be generated using the new, automated Poltype2 package.
Implementation of the force fields into the existing GPU-capable Tinker9 molecular dynamics
software will enable state-of-the-art simulation and binding free energy estimation.
The applicability of molecular simulation to design of therapeutics is limited by efficiency and
accuracy of the calculations. The objective of this proposal is to enable routine, accurate
computation of the thermodynamics of binding of small-molecule ligands to NAs. Toward that
end, several current systems of biological relevance will be investigated, including binding of
metal ions to G-quadruplex structures, fluorogenic ligands with RNA aptamers, novel antibiotic
drugs with the FMN riboswitch, and conformational dynamics of the P5abc domain of the
Tetrahymena group I ribozyme. The structures and functions of NAs are highly dependent upon
their ionic environment. The interplay between RNA local structural dynamics and global/tertiary
folding is an intriguing question being addressed experimentally. The ability to simulate these
complex energetic effects in the design of novel small molecule drugs and synthetically modified
oligonucleotides will be an important growth area for future medical advances. Development of
the accurate and transferable next-generation AMOEBA+ and AMOEBA+NN force fields will
open new paths toward understand and prediction of the behavior of natural and designed
nucleic acid molecules.

Public health relevance
NARRATIVE The proposed research is important to public health because it will lead to the critical understanding of how nucleic acids recognize ligands and drugs in terms of the basic thermodynamics underlying intermolecular interactions. Use of advanced force fields will allow computation of binding energetics to within an accuracy of 1 kcal/mol. The methodology and calculations proposed will help enable a new era of drug design where unique chemical structures are accurately designed and evaluated by computational means alone, especially for the targeting of small molecules-RNA interactions.